The Mid-Atlantic Neuroscience Diversity Scholars (MINDS) Program

PROJECT SUMMARY/ABSTRACT
This application is a five-year plan to create a Mid-Atlantic Neuroscience Diversity Scholars (MiNDS) program
to bolster the number of underrepresented minority (URM) students within the neuroscience academic pipeline
and build a foundation for URM students to succeed in graduate school and beyond. The program will
comprise a partnership between Temple University, Lincoln University, and University of Maryland – all
institutions with a strong commitment to educating URM students and a commitment to building neuroscience
research. Our program will recruit 9 scholars per year and provide them with the tools necessary for
persistence within academia focusing on 6 elements: (1) integrated research experiences during the academic
year, (2) immersive summer research experiences at R1 universities, (3) opportunities to build presentation
skills at local and national meetings, (4) coursework to build technical excellence in Neuroscience, (5)
professional skills training and mentoring to facilitate the transition to Neuroscience graduate programs, and (6)
outreach activities to foster community and build teaching skills. Scholars will participate in a 2-year bridge
program during their last two years of undergraduate study. Students in our MiNDS program will be provided
with a comprehensive research training experience, including financial support for academic year research at
their home institution, travel funds to present their research both at the MiNDS retreat, and at the Society for
Neuroscience annual meeting, and stipend to engage in summer research at T32 funded institutions, Temple
University or University of Maryland Baltimore, within the labs of faculty with exceptional behavioral or cognitive
neuroscience research programs and extensive undergraduate mentoring experience. The program will
provide MiNDS with a foundation of coursework and professional development to set the stage for the next
step of their neuroscience research career. This will include one-on-one faculty mentoring in oral presentation
skills, scientific writing, graduate school application review, and interview preparation. Additionally, students in
MiNDS will be paired with senior graduate student mentors during this summer experience to gain further
insight into the transition to PhD programs. The final core goal of the MiNDS initiative is to foster professional
development of both students and mentors through community outreach. MiND scholars will team with faculty
to develop outreach activities to engage 5th and 6th graders in neuroscience. These initiatives will position
MiND scholars for success in a career in academic neuroscience research. To sure this success, the MiNDS
program will be evaluated by our Advisory Board annually.

Public health relevance
PROJECT NARRATIVE While the US adult population is approximately 61.3% non-Hispanic white, 17.8% Hispanic or Latino, 13.3% African American, 5.7% Asian, and 1.5% American Indian, Alaskan Native, or Pacific Islander, the picture in academia is much different, with over 85% of full-time faculty identifying as non-Hispanic white or Asian. This loss of diversity is limiting our potential as a nation to build knowledge and improve human health. Our Mid- Atlantic Neuroscience Diversity Scholars (MiNDS) program is a five-year plan to bolster the number of underrepresented minority (URM) students within the neuroscience academic pipeline and build a foundation for URM students to succeed in graduate school and beyond.